The Alzheimer Disease Sequence Analysis Collaborative

The Alzheimer's Disease Sequencing Project (ADSP) is a national sequencing initiative focused on identifying
genetic variants that either protect from or increase the risk for late onset Alzheimer Disease (LOAD), with the
goal of accelerating development of effective therapeutics. The ADSP Discovery phase includes whole exome
sequencing (WES) of 10,571 unrelated non-Hispanic White (NHW) cases (N=5,606) and controls (N=4,965),
and whole genome sequencing (WGS) of 578 NHW and Hispanic (HI) familial samples. The Discovery Extension
Phase of the project added WGS on 434 new familial samples and 3,343 NHW, AA, and HI cases and controls
(collectively the ADSP-DEP). Preliminary analyses of these data confirm known LOAD genes and point toward
several new LOAD-related genes and their functional relationships to APP processing, neuroinflammation,
endocytosis, and cholesterol metabolism. The current Follow-Up Study phase (ADSP-FUS) will generate
>15,000 additional WGS focused on samples that `encompass the richest possible ethnic diversity', which will
include primarily HI and African-American (AA) datasets. This combination of diverse datasets derived from
case-control, cohort, and family study designs requires an intensive and comprehensive analytical effort to
uncover the wealth of information sequestered in the WGS. We (the Collaboration on Alzheimer Disease
REsearch [CADRE]) hypothesize that protective and risk genomic variants will provide potential therapeutic
targets for Alzheimer disease. Thus, the primary goal of this proposal is to integrate comprehensive
genomic analysis of the combined ADSP data (WGS, WES, SNP array) with extant biological data to
identify the highest priority variants and loci as candidates for downstream functional analysis. By
leveraging the data derived from the AA and HI admixed populations, we use their increased diversity to
accelerate and define likely targets. This goal will be met by: 1) Characterizing genomic variation in LOAD using
ethnically diverse datasets. We will supplement the ADSP-DEP and ADSP-FUS with additional, separately
funded WES and WGS data; 2) enhancing discovery and fine-mapping using admixture analyses in ethnically
diverse datasets; and 3) Prioritizing variants and genes by integrating statistical and biological information. For
the variants we identify, we will generate additional information from structural and gene expression data and
integrate all data into a genomically driven comprehensive biological network that will be used to prioritize loci
for functional testing as therapeutic targets.

Public health relevance
Narrative: Alzheimer disease (AD) is the most common form of dementia in older individuals and carries huge emotional and financial burdens for individuals and society. Large scale genomic data becoming available through the Alzheimer Disease Sequencing Project will be used to identify underlying variation that influences AD. Detailed analyses of these data will be focused on minority populations, which provides a powerful approach toward identification of causal variation, and will accelerate development of treatments and/or preventions for AD.